Compact X-ray Station for Protein Crystallography

DESCRIPTION (provided by applicant): In this Competitive Grant Revision to the Fast-Track SBIR: "A Compact X-ray Station for Protein Crystallography (CXS)," we describe proposed enhancements and upgrades to the Compact Light Source (CLS) that will result in a substantial increase in x-ray flux to the CXS. The CXS is a project to design and build a combination of x-ray optics, endstations, and software that use the monochromatic, tunable x-ray beam produced by the CLS. The CXS project, though not yet complete, has already resulted in an almost turnkey scientific instrument - a synchrotron-like x-ray system - for structural biologists at academic and corporate research centers. In order to make a significant reduction in data collection time, especially for small crystals, enhancements to the CLS are needed. In response to the NIH Notice: "NIH Announces the Availability of Recovery Act Funds for Competitive Revision Applications" - NOT-OD-09-058, we plan to expand the scope of the CXS grant to include several hardware upgrades to the CLS and to fund additional operations time. These efforts will result in significantly more x-ray flux and better reliability of the CLS, which together will greatly improve the impact and performance of the CXS. PUBLIC HEALTH RELEVANCE: The Compact X-ray Station for Protein Crystallography (CXS), along with the Compact Light Source (CLS), provides the technology to bring state-of-the-art macromolecular crystallography to structural biologists in their own local or regional laboratories. This tool will allow a wider community of researchers to conduct a broad range of structure determination experiments that will lead to better understanding of the role of proteins and other macromolecular assemblages involved in disease and therapy.

Public health relevance
The Compact X-ray Station for Protein Crystallography (CXS), along with the Compact Light Source (CLS), provides the technology to bring state-of-the-art macromolecular crystallography to structural biologists in their own local or regional laboratories. This tool will allow a wider community of researchers to conduct a broad range of structure determination experiments that will lead to better understanding of the role of proteins and other macromolecular assemblages involved in disease and therapy.